Neuroimaging Analysis Center (NAC)

The Neuroimage Analysis Center (NAC) is a National Resource Center in the Biomedical Technology Resource Center (BTRC) program that is developing image analysis algorithms and software tools to improve understanding of brain diseases and to enable innovative treatments. This competitive renewal application focuses on subject-specific analyses of medical imaging data. Underlying NAC's approach is a set of technical expertise and methodologies - Image analysis, applied statistics, tensor processing, time series analysis, and software engineering - that will enable the Center to exploit the atlas-based technologies developed in previous funding cycles to improve the analysis of individual patient data. The proposed work will be performed in four Technical Research and Development (TRD) projects and one Infrastructure project; it will be leveraged by outreach and operations activities, which include training in the use of 3D Slicer, the software platform supported by the Center. The four TRDs encompass microstructure imaging, spatio-temporal disease modeling, anatomical variability modeling, and Slicer engineering. The NAC team of investigators is augmented by subcontractors at GE, UMass Worcester, and Boston University, each of whom will provide unique expertise toward methodological and infrastructure development. The Driving Biomedical Projects (DBPs) will ensure that all Center activities continue to be highly relevant to NIH grantees. These DBPs include research in chronic traumatic encephalopathy, methamphetamine addiction and AIDS, schizophrenia, Alzheimer's disease, Huntington disease, autism, and image guided therapy. The translation of technological research into 3D Slicer as a platform for outreach represents a key deliverable In NAC's role as a resource center. The Center will continue to offer support and training at local and national venues as part of its outreach activities. Close collaboration with clinicians and scientists continues to be critical to the implementation of image analysis tools for the purpose of understanding the brain and treating Its disorders, an Important mission of the NIH.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Neuroimaging Analysis Center (NAC) Is a National Resource Center in the Biomedical Technology Resource Center (BTRC) program that is developing image analysis algorithms and software tools to improve understanding of brain diseases and to enable Innovative treatments.